Stratified Targeted Engagement from Primary Care to Physical Therapy (STEPPT): Reducing barriers for spine pain rehabilitation services in a Federally Qualified Health Center

Project Summary
Spine pain is among the most common and disabling health conditions for both non-Hispanic whites (NHWs)
and racial/ethnic minorities. Although Hispanics often report more severe musculoskeletal pain than NHWs,
they are less likely to consult a healthcare professional for pain management, and health care providers are
less likely to assess and treat pain in Hispanic patients. The overall objective of this proposal is to adapt and
test evidence-based, culturally informed practices at multiple levels of influence along the healthcare
continuum to improve access to and engagement in physical rehabilitation as a non-pharmacological treatment
option for Hispanics with spine pain. Aim 1 proposes a mixed-methods approach to adapt and manualize a
multilevel intervention to address modifiable factors contributing to ethnic disparities in rates of physician
referral and patient adherence to physical therapy referral for spine pain in a Federally Qualified Health Center
(FQHC) serving diverse, low-income communities near the US-Mexico border. Aim 2 will then assess
effectiveness of the manualized intervention, referred to as STEPPT (Salud de tu Espalda: Primary Care to
Physical Therapy), using a cluster-randomized stepped-wedge clinical trial in the FQHC setting. Compared to
standard care, we hypothesize that STEPPT will significantly reduce ethnic disparities in rates of physician
referral and patient adherence to physical therapy referral for spine pain. Successful completion of the
proposed aims will provide underserved Hispanic communities with scalable, sustainable, and effective options
for engaging in culturally appropriate pain care. This approach can serve as a model for FQHCs and other
healthcare systems to mitigate disparities in specialty services for a variety of health conditions that
disproportionately impact ethnic and racial minorities.

Public health relevance
Project Narrative Spine pain is among the most common and disabling health conditions for both non-Hispanic whites (NHWs) and racial/ethnic minorities. Although Hispanics often report more severe pain than NHWs, they are less likely to consult a healthcare professional for pain management and health care providers are less likely to assess and treat pain in Hispanic patients. Consistent with the U.S. Department of Health and Human Services National Pain Strategy, this proposal aims to mitigate ethnic disparities in access to and engagement in non- pharmacological treatment options for pain by addressing barriers at multiple levels of influence along the care continuum in a Federally Qualified Health Center serving diverse, low-income communities.